Evaluation of Brain and Cognitive Changes in Older Adults with MCI Taking Lithium to Prevent Alzheimer Type Dementia

Alzheimer’s disease (AD) is the most common cause of dementia in adults 65 years and older. Unchecked, the
disease will reach epidemic proportions in the United States and worldwide by 2050, and presently, there is no
intervention that has shown a clear effect on AD progression. Over the past several years, there has been
increasing interest in repurposing the use of lithium for diseases involving neurodegeneration. Lithium treatment
has been associated with neurogenesis in the hippocampus, up-regulation of important neurotrophic factors such
as B-cell lymphoma 2 (Bcl-2) and brain-derived neurotrophic factor (BDNF), and inhibition of glycogen synthase
kinase 3 (GSK-3) isoforms α and β. In particular, GSK-3α interacts with gamma-secretase playing a critical role
in the conversion of amyloid precursor protein (APP) to amyloid-beta (Aβ); lithium has been shown to reduce Aβ
production and memory deficits in AD transgenic mouse models. GSK-3β phosphorylates tau, a critical step in
the formation of neurofibrillary tangles, and lithium has been shown to reduce tau phosphorylation in vivo and in
vitro. That lithium may alter the AD trajectory is supported by numerous observational reports showing delay of
dementia onset in those treated with it. However, the results of the few human lithium trials conducted have been
mixed. Additional research is needed to determine whether lithium has a role as an anti-dementia agent. In
contrast to previous studies, we will implement an RCT with a more integrative, comprehensive approach than
done before involving state-of-the-art ultra-high field (7T) human MRI, neurocognitive assessment, and blood-
and CSF- based biomarker measurement to investigate the role of lithium as an anti-dementia agent. The specific
aim of this pilot-feasibility study is to examine the potential disease modifying properties of lithium in individuals
with mild cognitive impairment (MCI) in delaying conversion to dementia. The study will enroll and randomly
assign 80 individuals 60 years and older with MCI (amnestic type, single or multiple domain) to take lithium,
titrated to a maximally tolerated blood level (0.5 to 0.8 meq/L), or placebo for two years to assess lithium’s effects
on preserving cognition and delaying conversion to dementia. Participants will receive annual neurocognitive
assessment, blood- and CSF-based biomarker measurement, and 7T MR imaging of structural brain volumes
(e.g., hippocampal, total cortical gray). At baseline, all subjects will undergo PET imaging for Aβ. The following
hypotheses will be tested: H1: a) Participants randomized to take lithium for two years, compared to placebo,
will better maintain cognitive function, primarily in memory, which b) will be associated with changes in
biomarkers (e.g., GSK-3β, BDNF). H2: a) Participants randomized to take lithium, compared to placebo, will
have larger hippocampal volumes and lower total gray matter thinning, which b) will be associated with changes
in biomarkers and c) better cognitive function, primarily in memory. The exploratory aim examines whether lithium
is related to additional markers of enhanced brain integrity (e.g., lower level of microbleeds, higher white matter
integrity, better network connectivity, or decreased CSF phospho tau levels).

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the most common cause of dementia in adults 65 years and older. AD leads to a complete loss of memory and independent function, and, presently, there is no cure. Many studies suggest that lithium treatment may delay dementia onset or slow its progression. However, more research is needed to understand the extent of its anti-dementia properties, as well as its safety, if it will be deployed broadly in the general population. This study will examine whether lithium has anti- dementia properties in older adults who have mild cognitive impairment and are at risk of becoming demented.